Co-Presentation and Delivery of TLR Agonist Combinations with Subunit Antigens to Pathogen-Match the Immune Response

Project Summary/Abstract
Subunit vaccines are a key strategy for preventing infectious disease and related deaths.. However, the use of
subunit antigens, which elicit a weaker immune response than intact pathogen, has coincided with a need for
safe and effective adjuvants to improve vaccine efficacy, increase immune response, and reduce the size and
quantity of vaccine necessary to impart immunity. However, we lack a detailed picture of how engaging multiple
innate immune receptors simultaneously or sequentially, on the same cell, or different cells, alters the outcome
of the immune response. Our research team has engineered a new, flexible, pathogen-mimicking
recombinant outer membrane vesicle (rOMV) platform capable of presenting functional antigen together
with desired combinations of adjuvants. We intend to use this innovative technology to investigate how
different adjuvant combinations of TLR and NOD agonists engage the innate immune system and help direct the
immune response against viral and bacterial pathogens. Our hypothesis, to be evaluated through the
Specific Aims, is that rOMVs can co-present antigen with specific combinations of adjuvants to induce
pathogen-matched and protective immune responses (e.g., anti-viral and anti-bacterial). The specific aims
are to: Aim 1: Identify the molecular pathways elicited by individual or combinations of adjuvants on rOMVs.
rOMVs will be decorated with TLR and NOD agonists to understand how the resulting innate immune receptor
agonists activate and influence cell signaling pathways using established reporter cells, and determine how those
pathways are altered by co-presentation of TLR and NOD agonists. We will compare the response to soluble
combinations of the same adjuvants on both signaling and dendritic cell activation and maturation. Aim 2:
Determine how rOMV-adjuvant combinations direct the adaptive immune response to immunization using OVA
as a model antigen. We will use OVA antigen to characterize the adaptive immune response induced by rOMV
expressing single or combinations of adjuvants and compare them to single or combinations of soluble adjuvants.
We will identify the combination(s) that promote strong and directive T cell, B cell and/or memory responses.
Aim 3: Determine whether tailored rOMV adjuvant combinations can direct specific anti-viral and anti-bacterial
protective immunity. We will use OVA-presenting rOMVs, as well as pathogen-specific antigens presented on
rOMVs, decorated with different single or combined adjuvants in challenge models for both a viral (influenza)
and a bacterial pathogen (Listeria) modified to express OVA as well as the native pathogens (i.e., no OVA). We
will examine how innate signaling pathway activation and immune response correlate to protective immunity.
The anticipated outcome of the proposed studies is a mechanistic understanding of how adjuvant combinations
work at the molecular, cellular and organismal level to protect against viral and bacterial pathogens. The outcome
will help to define a set of guiding principles that we and other investigators in the field can use to more robustly
design adjuvant systems to maximize the efficacy of subunit vaccines.

Public health relevance
Project Narrative Subunit vaccines are a key strategy for preventing infectious disease and related deaths, but their efficacy suffers from poor immune responses. The goal of the proposed research is to determine how engaging the innate immune system can help guide the adaptive immune system to create pathogen-matched and protective immune responses against both viral and bacterial pathogens.